Mitochondrial translesion DNA synthesis

ABSTRACT
Mitochondrial DNA (mtDNA) integrity is critical for metabolism and cellular energy supply and human
health and longevity. Due to lack of repair mechanism and specified translesion synthesis (TLS) polymerase,
mtDNA contains higher contents of UV lesions. The high-fidelity mitochondrial DNA polymerase (Pol g) will
unavoidably encounter the UV lesions during mtDNA replication. Unlike other high-fidelity DNA polymerases
that lack TLS activity, we found Pol g possesses a metal regulated TLS activity. In the presence of magnesium
ion, Pol g exhibits no TLS activity, however, in the presence of physiological concentrations of manganese ion
alone or Mg/Mn mixture, Pol g can synthesize cross UV lesion cyclobutane dimer with efficiency near that on the
non-damaged DNA. We also discovered that Pol g has an extensive lesion recognition network that can sense
an upstream lesion as far as 10 base pairs in the presence of Mg2+, but completely ignores the lesion with Mn2+.
We hypothesize that Manganese ion can alter the elasticity of Pol g to be able to accommodate bulky lesions for
translesion synthesis. we will test the hypothesis by completing the Specific Aims 1) Mechanism of Pol g
integrated lesion bypassing, extension, and replication activities, 2) Investigation of Pol g long-range lesion
sensing and 3) Biophysical basis for metal-directed Pol g TLS. The proposed studies will illustrate how
mitochondrial replicase utilizing the essential metal ions to maintain genome integrity under UV radiation.

Public health relevance
PUBLIC HEALTH RELEVANCE UV radiation causes a large spectrum of lesions on mitochondrial DNA. We propose to study impact of the UV lesions on mitochondrial genome replication and integrity. The results of the proposed study will lay a solid foundation in understanding UV lesion on aging and human diseases.